The Role of M1 Leg Area in Volitional and Stereotyped Control of the Lower Limb

In the healthy nervous system, the development of intention and motor execution is a dynamic and highly
distributed process that originates in the brain. The intended action is transmitted along the axonal super
highway to smart circuits in the spinal cord that transform the descending command into coordinated patterns
of muscle activation. While much is understood regarding the control strategies the brain uses to drive upper
limb movements, relatively little is known about the central control of human locomotion. Further, failures of
function in one seemingly insignificant processing loop in the brain or periphery can, and often does, lead to
dramatic consequences that induce transient or permanent deficits in motor control. A particularly palpable
example of this is the consequences resulting from spinal cord injury (SCI), which, in extreme cases, can
render a person completely unable to interact with the world around them. Such nervous system injuries and
disorders have long-term health, economic and social consequences in both the civilian and Veteran
population. Despite the best available medical treatments, hundreds of thousands of individuals endure a long
life post-SCI with sensorimotor deficits that dramatically affect their quality of life.
The specific objective of this project is to build fundamental knowledge of how motor cortex (MI) controls
voluntary, as well as stereotypic, lower limb movements, and then to design both a brain-spine interface
leveraging a fully implanted hardware system, as well as a first of its kind end-point brain-machine interface for
lower limb prosthetics. We will study the basic function of nonhuman primate motor cortices during a variety of
hind limb movements, including passive walking on a treadmill, during obstacle avoidance, and direct endpoint
control on a sitting flywheel while recording high-fidelity neural population data and kinematics. Finally, our
results will be interpreted in the context of supporting a translational clinical study in humans to provide a new
rehabilitation pathway for Veterans with spinal injury, as well as neuroprosthetic pathway for amputees. We will
conclusively determine the strategies employed by nonhuman primate motor cortex to both drive and adjust
hind limb placement during locomotion and we will determine if motor cortex activity consequently changes
between so-called “automatic” movements (e.g. walking on a treadmill), and volitional, highly precise
movements (e.g. end-point control on a flywheel).
The proposed study will work with rhesus monkeys trained to walk on an instrumented treadmill, across a flat
corridor, freely within a large naturalistic roaming space, as well as controlling the pedal location along a 2-
dimensional flywheel. Animals will be implanted with a) two silicon microelectrode arrays in MI-leg, and
premotor area (PMd) containing movement planning information; b) an implantable pulse generator connected
to a custom epidural spinal cord stimulation microelectrode array; and c) electromyography sensors in key gait
muscles of the lower limb. Animals will be evaluated across all locomotor contexts, as well as in their
customized home-cage, using wireless data transmission. We will evaluate the long-term use of the BSI both
to restore functional locomotion, and to support other daily nonhuman primate activities. Finally, we will
leverage the knowledge gained about the motor cortex’s role in locomotion, as well as our previous
development of a brain-spinal interface, to deploy a fully-implanted brain-spinal interface for human translation
within the VA for application to veteran locomotor rehabilitation.

Public health relevance
There are over 1,600 major limb amputations to-date in military operations OEF, OIF, and OND (CRS Report). Additionally, in 2013 alone there were nearly 27,000 (QUERI) Veterans with spinal injuries (SCI) and related disorders cared for by Veterans Affairs who all stand to benefit directly from this project. This Merit Award project aims to build fundamental knowledge of how motor cortex (MI) controls voluntary, as well as stereotypic, lower limb movements, and then to design both a brain-spine interface leveraging a fully implanted hardware system combining wireless neural recording, stimulation, and motion capture technologies borrowed from industry and born from our laboratory, with the mathematical tools to explore use of a neuroprosthetic for therapeutic delivery of spinal stimulation. By establishing a robust understanding of the cortical control of hind limb movement, and piloting a fully implanted brain-spinal interface, we will have obtained the critical scientific information needed to advance toward a first-in-human study of a restorative BSI in Veterans with paraplegia.